Investigation of sirtuin 1 expression in mice model of Alzheimer's disease over age

Project Summary
Sirtuin 1 has been implicated in multiple functions is thought as one of the candidate molecules for promoting
healthy aging, because of its neuroprotective roles against several age-related pathologies, and several studies
done in animals showed an association between sirtuin 1 and lifespan elongation. Sirtuin 1 has been shown to
impact several brain disorders such as neurodegenerative disorders, such as Alzheimer’s disease. Therefore, it
is important to have a tool for non-invasive measurement of sirtuin 1 expression and function in vivo, and PET
imaging would be an ideal tool.
Unfortunately, to date, there are no suitable non-invasive neuroimaging tools for investigating these processes
in animals or in man until we developed the first PET imaging probe for sirtuin 1 recently. The development of
techniques for visualizing sirtuin 1 in vivo represents a key step in understanding both the normal function and
pathophysiology of sirtuin 1 in brain. Moreover, these techniques these techniques will accelerate the
discovery/development of small molecule therapeutics that selectively interacts with sirtuin 1. The project is
aimed to measure the expression of sirtuin 1 in brain of Alzheimer’s Disease animal model and wild-type mice
over age, using our novel PET imaging probe, [11C]CWL-1, prior to first-in-human imaging.

Public health relevance
Project Narrative Sirtuin 1 is a promising target for promoting healthy aging and lifespan elongation. However, the sirtuin 1 expression changes over age and in Alzheimer’s disease brain is poorly understood. This project is to validate a new in vivo imaging tool for probing sirtuin 1 using PET in animal model over age.